Partners in Research: Building capacity for community-driven research to advance health equity

ABSTRACT
Structural factors of health inequities are the systemic and societal conditions that contribute to disparities in
health among different populations. These disparities often stem from racial and socioeconomic discrimination
that are deeply intertwined in historical, social, economic, and political processes, and overtime have limited
access to quality education, job opportunities and wealth accumulation for minoritized communities. Therefore,
these communities are more likely to experience disinvestment in their neighborhoods leading to reduced
access to health care and healthy foods, and lower educational and employment opportunities. The Partners
Engaged in Equity Research Hub (PEER Hub), based at the University of Michigan School of Public Health,
leverages our institutional and national networks and training and technical assistance (TTA) expertise to
support community-led interventions to advance health equity, especially in the areas of neighborhood and
built environment, social and cultural context, access and quality of community health care services, economic
development, and nutrition and food environment. We bring together an interdisciplinary team of researchers,
practitioners and community-based organizations with expertise and experience in addressing structural
factors contributing to health inequities. Our overall goal is to support localized solutions tailored to the unique
needs of the population while fostering a sense of ownership and empowerment, all crucial for sustainable
change. Working in close collaboration with the NIH ComPASS Network, Coordinating Center and a
multidisciplinary panel of experts (MEP), the UM PEER Hub will: 1) provide centralized administrative,
operational, and logistical infrastructure to support the network of community-led (CHESI) research studies; 2)
provide locally relevant proactive technical assistance to assigned CHESI projects to support high quality
implementation and future sustainability of the community-led research initiatives, and to establish data
infrastructure to support and facilitate cross-site research coordination; 3) build capacity to conduct high quality
community-led health equity research through tailored training and technical assistance; and 4) support and
enhance effective community-academic partnerships and mentor the next generation of community engaged
scholars. In keeping with our community-focused approach, our Research Hub will be guided by a Community
Steering Committee to help ensure equitable practices within our own work and across our team, partners, and
community sites.

Public health relevance
The Partners Engaged in Equity Research Hub (PEER Hub), leverages our institutional and national networks and training and technical assistance (TTA) expertise to support community-led interventions to advance health equity, especially in the areas of neighborhood and built environment, social and cultural context, access and quality of community health care services, economic development, and nutrition and food environment. Working in close collaboration with the ComPASS Coordinating Center and a multidisciplinary panel of experts (MEP), the UM PEER Hub will provide locally relevant proactive technical assistance to assigned CHESI projects to support high quality implementation and future sustainability of the community-led research initiatives.